Analysis Project - Gene Therapy for Metachromatic Leukodystrophy

Team 2 - Analysis (in vitro and in vivo assessment of the function of the AAV-based vectors for MLD including assessment of ARSA activity, distribufion and immune responses)